Single Molecule Enzymology with Printed Carbon Nanocircuits

The protein kinase superfamily is rich in disease-driving mutations. Experiments described here focus on the
catalytic domain of cAMP-dependent protein kinase A (PKA-C). This enzyme catalyzes the phosphorylation of
numerous proteins during the excitation-contraction coupling mechanism of normal heart muscle function.
Mutation-driven, aberrant phosphorylation by PKA-C is directly linked to various cardiac dysfunctions, including
dilated cardiomyopathy (DCM), hypertrophic cardiomyopathy (HCM), and diabetic cardiomyopathy. We will
observe at the single molecule level the catalytic subunit of PKA-C operating on physiological proteins in both
functional and cardiac disease-associated situations. PKA-C, the best characterized protein kinase, is ideal for
novel, single molecule studies. Its catalytic steps have been well-studied including X-ray structures of all steps
during catalysis. The dynamic features of catalysis and allostery as well as inhibition by pseudo-substrates have
been characterized by NMR and classic kinetics. We will use well-defined cardiac proteins (RyR, PLN, and
Troponin C) as substrates for phosphorylation by both wild-type and cardiac disease-associated mutants of PKA-
C. Sub-microsecond empirical data will be combined with the computational tools of MD simulations integrated
into a graphical tool (Local Spatial Patterning) for mapping entropic changes that correlate with allosteric control
over this highly regulated, enzymatic switch. Thus, the approach will uncover a dynamic portrait of PKA-C in both
diseased and normal physiologies. In Specific Aim 1, we will engineer a single-walled carbon nanotube field
effect transistor (SWNT FET) system to record single molecule dynamics with unprecedented, 35 ns time
resolution. This approach will be combined with inkjet- and 3D-printing to allow rapid design-build-test cycles
and broad adoption of the technique beyond this project. In Specific Aim 2, we bioconjugate wild-type PKA-C to
the SWNT FET and characterize the catalytic machinery of PKA-C using three peptides – the substrates
Kemptide and SP20, along with the pseudosubstrate IP20 from the heat stable protein kinase inhibitor (PKI).
Nucleotide binding, opening and closing of the catalytic cleft, requirements for pH and metal ions (Ca++ vs. Mg++)
will establish a baseline set of motions at sub-microsecond timescales. In Specific Aim 3, we will characterize
the phosphorylation of three well-studied, cardiac substrates, an activity critical to healthy heart physiology. We
first define the motions that correlate with phosphorylation using peptides that flank both sides of the P-3-P+1 P
site when docked to the active site cleft. These flanking regions are docked onto allosteric sites in the C-lobe.
We will then examine mutations in the C-lobe of PKA-C that drive Cushing’s syndrome and a set of recently
described PKA-C mutations that drive the formation of potentially lethal cardiac myxomas. The studies outlined
here leverage recent advancements in nanotechnology, and the approach can be adopted by other
laboratories, promising broad impact within the biomedical community.

Public health relevance
The enzyme protein kinase A (PKA) plays a crucial role in heart beats by catalyzing the phosphorylation of key proteins in the heart’s excitation-contraction coupling mechanism. Mutated and dysfunctional PKA is directly linked to Cushing’s disease and cardiac myxomas. As a first step towards the eventual development of therapeutics for such diseases, this project applies a high-speed observation tool to dissect how PKA functions both normally and abnormally, including in its mutant forms and operating on key proteins in the heart.